Neural Underpinnings and Sensory Feedback Augmentation During Split-belt Treadmill Training in People with Multiple Sclerosis

Project Summary
Multiple Sclerosis (MS) is the most common neurodegenerative disease affecting young adults, with the average
onset at 31 years of age. This is pertinent because the over 2 million people with MS (PwMS) are likely to
experience the effects of the disease for approximately half their lifespan. Walking difficulties are a common
challenge faced by PwMS, leading to an increased risk of falls, musculoskeletal injury, and a reduced quality of
life. More specifically, most PwMS experience significant gait asymmetries between their legs. Split-belt treadmill
training, where the speed of each leg is controlled independently, improves gait symmetry in PwMS, Parkinson’s
disease, and stroke. Additionally, sensory feedback augmentation produces improved gait performance and
motor coordination within these populations. However, there is limited research investigating the neural
mechanisms underlying these gait adaptations and whether sensory augmentation can elicit enhanced
adaptation during split-belt treadmill training. The objective of this project is to identify the neural underpinnings
of split-belt treadmill training and test the efficacy of transcutaneous electrical nerve stimulation (TENS) to further
improve gait adaptability. It is hypothesized that participants will have heightened activity in the cortical
sensorimotor integration regions during split-belt treadmill training, compared to when the belts are moving the
same speed. Additionally, it is hypothesized TENS will enhance gait adaptability during split-belt treadmill
training. In this F31 proposal, the candidate, Andrew Hagen will recruit 30 PwMS and 30 neurotypical controls.
Participants will undergo split-belt treadmill training while cortical activation is measured using functional near-
infrared spectroscopy (fNIRS). Separate split-belt treadmill training sessions will also utilize the application of
TENS, and the effects on gait adaptability will be assessed using kinetics and kinematics. By enhancing our
understanding of the underlying neural mechanisms and evaluating sensory augmentation to enhance split-belt
treadmill training, this project aims provide a significant step toward creating a targeted rehabilitation paradigm
to improve gait symmetry long term that would improve mobility, independence, and quality of life for not only
PwMS but the tens of millions of people who experience gait dysfunction. Mr. Hagen’s long-term goal is to
become an academic, translational scientist investigating neural injury rehabilitation. Mr. Hagen will train in a
state-of-the-art environment with an exceptional mentoring team at Colorado State University. The sponsor, Dr.
Brett Fling, has an extensive background studying sensorimotor control and adaptation in PwMS. Consulting
mentors Drs. Jaclyn Stephens and Mark Manago will provide expertise on functional neuroimaging and
translational research to prepare Mr. Hagen for a career as a translational scientist. Mr. Hagen’s career
development plan consists of 1) training in neuromechanics and neuroimaging, 2) strengthening his background
in neural injury rehabilitation methods and clinical application, and 3) further developing his professional and
communication skills through interaction with his mentors, coursework, clinical exposure, and conferences.

Public health relevance
Project Narrative People with multiple sclerosis commonly experience challenges with walking, resulting in a higher risk of falls and a significant impact on their daily lives. This project aims to identify brain activity patterns during walking adaptation and assess the impact of peripheral sensory stimulation on walking performance in people with multiple sclerosis. By gaining insights into how walking adaptation occurs and providing novel evidence for a portable, cost-effective rehabilitation approach, this research is a necessary step leading to improved walking performance for the tens of millions of people who experience walking impairments.